Clinical Core

Project Summary
The proposed Center for Lupus Research will take advantage of a wide range of technologies that will be applied
to monitor molecular pathways driving disease activity in patients toward the ultimate goal of a personalized
approach to therapy. Cumulative efforts from this project will generate an invaluable sample repository as a
resource both for the proposed studies and future experimental questions. Thus, the necessary and important
mission of the Clinical Core is to ensure that all patients will have a comprehensive clinical assessment and that
patient samples and clinical data will be systematically catalogued and tracked, adequately stored, and
appropriately disseminated.
This Core will arise from the Divisions of Pediatric Rheumatology at Children’s Health at UT Southwestern
Medical Center (UTSW) and Nationwide Children’s Hospital at Ohio University (NCH) and take advantage of the
availability of samples from well-characterized pediatric SLE patients, who manifest disease early in life, often
present extreme phenotypes and lack co-morbidities that confound the phenotypes. Blood samples obtained via
this Clinical Component will serve as the source of pediatric patient samples for the entire proposed Center for
Lupus Research.
The Clinical Core will build upon existing strengths and expand to coordinate sample and data acquisition,
processing, storage, and distribution for this P50 grant proposal. The Core will capitalize on the long-standing
collaboration between Drs. Pascual and Wright and extend the collaboration to Dr. Ardoin in order to expand the
Core’s capabilities and the outstanding organization developed to liaise the clinic and the research laboratory.
These strategies and strengths will enable scientists of the proposed Center for Lupus Research from different
institutions to work together seamlessly and allow investigators to track clinical and laboratory data associated
with samples to ensure scientifically sound correlative studies and facilitate a truly synergistic program.